Interdisciplinary Anesthesiology Research Training Program

Abstract
Anesthesiology is an interdisciplinary medical specialty requiring its practitioners to have a broad fund of
knowledge, including pharmacology, physiology, and engineering and the ability to apply this knowledge in
both controlled and emergency situations. In addition to providing trainees with exceptional clinical knowledge
and skills, the Anesthesiology Department as well as the larger academic community at the University of
California, San Diego (UCSD), provides a world-class environment for high quality training in research. Two
particular basic science research strengths at UCSD include the Departments of Pharmacology and
Engineering. Anesthesiologists including both basic scientists and clinicians have productive interactions and
collaborations with faculty in these two disciplines. Thus, the primary goal of this renewal T32 grant application
remains to train the next generation of clinician scientist in the Department of Anesthesiology to address
important questions in the discipline by leveraging the potential interdisciplinary training available in
collaboration with faculty in pharmacology and engineering. These interactions serve as guidance for our
fellows; however, fellows with their mentoring team have the ability to work beyond, within, and in larger
collaboratives to undertake research at the broadest level to involve as many disciplines necessary to
adequately address the questions asked. This goal will continue to be facilitated by approaching primary
questions in anesthesia with an interdisciplinary training focus; however, the program will remain flexible to
expand research scope as the interests of fellows develop. This training grant will provide post-graduate
trainees (MDs or MD/PhDs) with a 2-year research experience consisting of a broad focus on the basic
molecular mechanisms of drug action and/or exploration of a variety of engineering disciplines. Emphasis will
be on defining novel mechanisms of drug action for therapeutic interventions, applying engineering principles
to create devices, model physiology and pathophysiology using mathematical and theoretical approaches,
investigate biomaterials to facilitate non-invasive monitoring, and generation of biometric and blood derived
biological data, among other projects to enhance human health and the patient experience. To achieve this
overall goal, the training experience has two specific aims: i) expose fellows to a culture of science and
investigation present in the Department specifically and the campus broadly and ii) achieve competency in the
allied elements of a research career, e.g. experimental design, data analyses, presentations, manuscript
preparation and publication and how best to obtain research funding as well as lab management and job
interview skills. We strongly emphasize collegiality and ethics in the research environment. In achieving our
strong commitment to the development of the clinician scientist, our overriding mission is the training of the
next generation of clinician scientists who have the foundation of knowledge and fundamental tools coupled
with the passion and commitment to affect translational research.

Public health relevance
Project Narrative The goal of this training program is to develop the next generation of clinician-scientist in the field of Anesthesiology. We propose to continue a unique training experience that addresses core clinical problems in anesthesiology and utilize collaborative research experiences across the campus. Fellows with their mentoring team have the ability to work beyond, within, and in larger collaboratives to undertake research at the broadest level to involve as many disciplines necessary to adequately address the questions asked to solve unique problems.